Outreach Core (PCORE)

Over the next five years, PCORE will continue to bring together myriad communities, and researchers and
students at CCNY and MSK, to build on our strong foundation of community-engaged approaches to develop,
implement, and disseminate evidence-based cancer prevention and early detection practices. PCORE will also
spearhead new, cutting-edge initiatives, including in cancer precision prevention/medicine. PCORE will seek
to increase impact by focusing on translating data into policy to facilitate uptake of inclusive, evidence-based
practices into public health, clinical practice, and community settings. Overarching all PCORE activities is a
consideration of the specific risks and assets among the communities with which we work. AIM 1. To build
upon and strengthen PCORE's community-academic partnership assets and infrastructure to facilitate
community engagement and community capacity building, and to extend our reach for the implementation and
dissemination of cancer disparities reduction activities: a) Strengthen and grow community-, faith-, and
occupation-based organization partnerships and implement training activities, enabling these organizations to
independently conduct cancer disparities reduction activities; b) Deepen safety net health system partnerships
(e.g. St. Barnabas Hospital Health System [a CUNY School of Medicine training site], Jamaica Hospital Medical
Center, NYC H+H [municipal healthcare system], Federally Qualified Health Centers [FQHCs], MSK Ralph
Lauren Center [RLC]), and the reach of the Mobile Health Unit to expand the capacity to provide additional at-
risk communities with cancer disparities reduction activities; and c) Support and collaborate with the U54
Partnership Cores, including the Linguistic and Cultural Responsiveness Shared Resource and Research
Education Cores, and with the U54 Working Groups and the MSK P30 CCSG to engage low socioeconomic
status, LEP, and other underserved health disparity populations, and CCNY and MSK researchers, to maximize
bidirectional knowledge exchange, develop best practices, impact policy, and engage the community in
targeted programs and studies. AIM 2. To leverage the expanded infrastructure developed in Aim 1 to further
develop, implement, and disseminate robust i) community-engaged cancer disparities reduction outreach,
education, research, and comprehensive screening packages that include precision prevention/precision
medicine, and patient navigation into and through care; and ii) policy development to address socioeconomic
determinants of cancer outcomes, changes in screening guidelines with evolving evidence, and disparities in
priority areas guided by community needs assessments and the NCI National Cancer Plan: a) Precision
prevention (e.g. genetic ancestry, genetic screening)/precision medicine (e.g. immunotherapy, liquid biopsies,
cancer genomics, targeted therapies) programs and research; b) Prevention-risk reduction (tobacco, obesity,
diet, physical activity, occupation-linked risk, HPV); and c) Screening and navigation into and through treatment
for, and research on, colorectal, prostate, breast, lung, and HPV-associated cancers.

Public health relevance
As per solicitation PAR-23-308 Comprehensive Partnerships to Advance Cancer Health Equity (CPACHE) (U54 Clinical Trial Optional) Project Narrative: Do not complete